Dopaminergic Mechanism for Familiarity and Memory Interference

Abstract
Early signs of age-related cognitive decline are associated with deficits in novelty processing. Older individuals
often mistake new events for familiar ones. This bias for familiarity is thought to cause memory interference,
which occurs when established memories from everyday life interfere with newly acquired information. The
brain dysfunctions promoting the reactivation of familiar memories and causing interference in aging remain
unknown. Studies show that older adults with reduced familiarity bias exhibit enhanced cognitive abilities,
emphasizing the need to investigate the neural circuits involved in familiarity and memory interference in aging.
In older adults, reduced LEC activity is linked to difficulty distinguishing new from familiar objects, indicating
insufficient activation by novelty-signaling inputs. The exact circuit changes that give rise to this dysfunction
have not been identified. Our latest research suggests that dopamine neurons (DANs) that project to the LEC
in mice deteriorate with age. Previously, we demonstrated that inhibiting DANs in young mice — thereby
simulating the aging effect — leads to a bias towards familiarity. Based on these findings, we propose that
aging-related decline in DAN functions predisposes the LEC to prioritize familiarity, enhancing memory
interference. In this project, we seek to investigate how dysfunction in LEC-projecting DANs affects memory
interference in old mice, using the latent inhibition paradigm. We will examine the role of LEC DA release in
promoting familiarity processing in Aim 1 and assess DANs' effect on reactivating neuronal representations of
familiar memories in the LEC in Aim 2. Experiments in Aim 1 will use fiber photometry and optogenetic
manipulations to measure DA transients in the LEC during the transition from novelty to familiarity and
establish a role of DA in memory interference. Aim 2 will determine if reactivation of neuronal representations
of familiar stimuli in the LEC during a recall phase is necessary to produce memory interference. We will use
activity-dependent tagging strategies to label neuronal presentations in the LEC and examine their modulation
by DANs. The project will determine the LEC microcircuits involved in proactive memory interference and will
build the foundation for further inquiry into why older adults are biased towards familiarity, hindering novelty
detection and learning in rapidly changing environments.

Public health relevance
Narrative The aging global population is facing an increased risk of cognitive decline, often characterized by familiarity bias and memory interference. Our research focuses on identifying the neural circuits behind memory interference to understand these deficits. We aim to explore how age- related deterioration in the dopaminergic innervation of the lateral entorhinal cortex contributes to memory interference.